Gene Transfer Core, NIDCR-DIR

In FY22, the Gene Transfer Core successfully provided following services:

Pronuclear injection service: 13 CRISPR-based gene editing constructs were injected to generate 19 transgenic lines.

CRISPR-based gene editing service: The average efficiency for generating KO and KI mice for CRISPR-based constructs was 20% and 23%, respectively.

Cryopreservation and IVF services: Sperm from 34 mouse models were cryopreserved for 8 Principal investigators (10 investigators). Sperm from all mouse models were stored in two separate buildings. 16 sperm straws were thawed for 20 IVF sessions.

Genotyping service: 480 tail biopsies were purified and used for genotyping by PCR analysis.